THE KIDNEY IN HYPERTENSIVE BLACK MEN AND WOMEN

The purpose of this study is to evaluate the mechanisms of deranged renal hemodynamic adaptation to high dietary sodium intake in Black hypertensive patients.